Mitochondrial mechanisms of maternal age effects on offspring health and lifespan

7. PROJECT SUMMARY
Advanced maternal age at the time of reproduction decreases offspring lifespan and health in a range of species,
including humans. The mechanisms controlling maternal age effects on offspring are unknown, however.
Mitochondria are prone to damage and dysfunction with age and are maternally inherited, suggesting they may
play a role in intergenerational maternal effects on offspring health. Our work shows that offspring from older
mothers have shorter lifespan, lower reproduction, decreased health, and altered behavior relative to young-
mother offspring. We found that these changes are associated with higher mtDNA per cell, more mitochondria,
larger mitochondria, decreased mitochondrial intermembrane area, lower oxidative potential, lower ATP content,
and altered reactive oxygen species (ROS) levels. Our results and the literature on mitochondria in aging led to
our hypothesis that mitochondrial dysfunction in advanced maternal age causes accumulation of dysfunctional
mitochondria in offspring through compensatory biogenesis and decreased autophagy during development. This
disrupts offspring mitochondrial function and mitochondrial-nuclear communication, leading to accelerated
offspring aging. The objective of this project is to understand the mitochondrial mechanisms by which maternal
age determines offspring aging. In this study, we will: (1) identify the maternal mitochondrial mechanisms that
trigger maternal age effects; (2) identify the developmental mechanisms causing accumulation of mtDNA and
damaged mitochondria in old-mother offspring; and (3) identify the offspring mitochondrial mechanisms involved
in negative maternal age effects and determine if these mechanisms are ROS-dependent. This work will be
accomplished using qPCR and RNA-Seq to quantify mtDNA and controls on metabolism, signaling, and
dynamics; imaging to quantify mitochondrial ultrastructure and mitophagy, and pharmacological and RNAi
manipulation of maternal and offspring mitochondria to test mechanisms. We will use biochemical, respirometry,
and imaging approaches to measure mitochondrial efficiency. Additional biochemical and imaging approaches
will be used to quantify ROS and cellular damage. We will use lifetable experiments to measure lifespan and
reproduction in response to maternal age or mechanistic tests. Studies will be on both female and male offspring.
Our study system is the rotifer Brachionus manjavacas—a short-lived, aquatic, microscopic invertebrate with
unique advantages as a model for investigating maternal age effects. Our approach will identify the cellular
mechanisms by which advanced maternal age causes accumulation of mtDNA and damaged mitochondria in
offspring; changes offspring mitochondrial dynamics, structure, and function; and decreases offspring fitness. If
successful, this research will advance the field by revealing drivers of accelerated aging in offspring due to
maternal age effects and by identifying mechanisms underlying a poorly understood cause of interindividual
variability in healthspan and lifespan. Our findings will have implications for understanding age-related changes
in female fertility and for identifying potential targets for treatment of age-related dysfunction.

Public health relevance
8. PROJECT NARRATIVE/RELEVANCE TO PUBLIC HEALTH This project will contribute to our understanding of the molecular mechanisms that cause accelerated aging, decreased health, and shorter lifespan in offspring from older mothers. This study is innovative and significant in its use of an emerging model system in aging research to examine the role of mitochondrial dysfunction in maternal age effects on offspring aging. Our work has the potential to identify a cause of interindividual variability in lifespan and to identify targets for therapies to improve health and increase lifespan.